A & R

The laboratories and offices of the COBRE PI, Dr. Igor Roninson, COBRE target faculty Dr. Michael Shtutman, the Co-Directors of the COBRE Microscopy/Flow Cytometry Core, Dr Chang-uk Lim and Dr. Gary Schools, are scattered in various inadequate rooms and laboratories between floors 3 and 7 of the Coker Life Sciences Building (CLS) on the Columbia Campus of USC in space that was temporarily provided to Pharmacy from the Department of Biology. This lack of cohesive modern molecular biology laboratory space is disruptive, inefficient, and raises many obstacles for Dr. Roninson's research program and the CTT COBRE. This A&R request is for $300,000 of support toward a $1,150,000 renovation project on the 7th floor of the Pharmacy wing of CLS that will result in 4,857 s.f. of new modern office and research space for the CTT COBRE and Dr. Roninson's entire program. Specific Aim 1. To renovate space on the 7th floor of the Pharmacy Wing of the Coker Life Sciences Building on the USC Columbia campus to house the proposed CTT COBRE. This space will provide modern office and laboratory space for (1) the COBRE PI, (2) COBRE target faculty Michael Shtutman, (3) the COBRE Microscopy/Flow Cytometry Core and its Co-directors Dr. Gary Schools and Dr. Chang-uk Lim, and (4) part of the COBRE Functional Genomics Core. Additionally, this space will house the Administrative Coordinator for the COBRE Center for Targeted Therapeutics, a Conference Room, and a Break Room.

Public health relevance
This request will complement and complete an extensive renovation of space to accommodate the Center for Translational Therapeutics undertaken by the SC College of Pharmacy, University of South Carolina, to provide first-rate facilities to the CTT group and consolidate a large component of the CTT into contiguous research and office space, to promote interactions and facilitate collaboration